Molecular Regulation of Stem Cell Aging

SUMMARY
The loss of tissue homeostasis and regenerative capacity with age underlies some of the most challenging
health issues in the elderly. A major contributor to age-related declines in the structure and function of many
tissues is the loss of stem cell function that occurs during the aging process. To slow, arrest, or even reverse
those age-related declines in stem cell function would represent a major therapeutic success based upon
advances in both stem cell biology and the biology of aging.
The primary focus of this Program is to understand the molecular basis of age-related changes in stem cell
function. An underlying premise is that such an understanding will reveal ways to enhance aged stem cell
function and tissue repair. Based on many studies, including innovative work from the laboratories of this
Program, there is increasing evidence of dysfunctional genetic, epigenomic, transcriptional, and metabolic
changes in stem cells with age. A central concept that is woven throughout this Program is that systemic
factors may mediate some of these changes, and that, conversely, cell-extrinsic influences may restore
youthful properties to aged stem cells. Another unifying concept is how changing genetic and epigenetic
diversity in stem cell populations combine with age-associated alterations in their niches to create an ever
changing adaptive landscape, one that may select for subsets of stem cells that are actually suboptimal for
tissue homeostasis and repair.
To examine those concepts experimentally, this Program includes Projects that focus on stem cell
populations from three tissues – muscle (Project 1), brain (Project 2), and blood (Project 3). In the current
proposal, we extend our previous studies along several themes that are shared among the Projects. These
themes include changes in stem cell heterogeneity with age, the role of metabolic changes as determinants of
the aged epigenomic state, and the impact of rejuvenating interventions on stem cells and their niches. The
Projects are supported by three essential Cores – an Administrative Core; a Single Cell and Spatial Proteomics
Core, which includes cutting-edge spatial proteomic technologies; and a Bioinformatics Core both to serve as
the critical hub for storing, processing, visualizing, analyzing, and sharing data from the three Projects, and
also to develop pioneering spatial transcriptomics. Overall, the investigators who are Project Leaders and Core
Directors are internationally recognized experts in their respective fields. They bring to the Program the full
breadth of expertise, creativity, and records of accomplishment to assure an integrated, innovative, and highly
successful Program to explore the molecular mechanisms of stem cell aging and rejuvenation. The successful
completion of the studies of this proposal has the potential to advance therapeutics to enhance tissue
homeostasis and repair in elderly individuals.

Public health relevance
NARRATIVE – OVERALL Stem cells, which are present in most tissues, are responsible for maintaining tissue structure and function during normal activity and for repairing tissues in response to injury. One of the hallmarks of aging is the decline in the ability of tissues to perform these functions due at least in part to the decline in stem cell function with age. The studies of this proposal are designed to examine why stem cell function declines with age and how to restore youthful function to aged stem cells.